"Cue Labeling as a Tool to Regulate Craving During Abstinence from Smoking”.

PROJECT SUMMARY / ABSTRACT
As the leading preventable cause of death, tobacco smoking causes nearly 8 million deaths globally each
year. Nearly 70% of U.S. adults who smoke want to quit, but only 7.5% manage to quit for 6 months or more.
Cigarette craving, induced or exacerbated by exposure to smoking-related cues, is a major factor in lapses in
abstinence. The goal of this project is to evaluate whether a cognitive technique for reducing negative affect,
called Affect Labeling, can be adapted into a new strategy for reducing craving in people who smoke.
Affect Labeling refers to the act of naming an emotional experience or an emotion-inducing stimulus. Affect
Labeling reduces self-reported distress and activity in the amygdala, a key brain region linked to emotional
experience and response. Given that negative affect and craving may share neural and psychological
underpinnings, interventions that downregulate negative affect (e.g., Affect Labeling) may be effective in
downregulating craving. To examine this possibility, the Cue Labeling task was developed as a tool to regulate
craving and tested on 47 adults (Pittsburgh study) and 19 emerging adults (LA study) who smoked daily. The
objective of this proposal is to analyze these two datasets, in order to: 1) Examine the overlap in the neural
substrates of cue-elicited negative affect and craving; 2) Examine the effect of Cue Labeling on self-report
and neural markers of craving; 3) Identify the neural mechanism of Cue Labeling; and 4) Compare the neural
pathways of Cue Labeling and Cue Reappraisal, another cognitive technique for regulating craving.
Participants completed the Cue Labeling and Cue Reappraisal tasks during fMRI after overnight abstinence
from smoking. In the Cue Labeling task, participants viewed either neutral picture cues (e.g., a man holding a
cup) or cigarette picture cues (e.g., a man holding a cigarette), and they selected one of two words (labeling
condition) or one of two pictures (matching condition) that fit the cue. In the Reappraisal task, participants
reinterpreted a cigarette cue in a way that made it less enticing, or they passively viewed neutral, negative, or
cigarette cues. During Cue Labeling, participants in the Pittsburgh study provided ratings of their craving
following each cue. During Reappraisal, all participants provided craving ratings following each cue. Primary
analyses of activation will focus on data extracted from pre-defined ROIs in the salience network and other
regions associated with craving, such as the striatum.
Positive findings would provide the first evidence that Affect Labeling can be adapted for regulating craving.
If confirmed in trials, the potential clinical impact of this finding could parallel that of Affect Labeling. In the
same way that Affect Labeling has been identified as a method for enhancing exposure therapy for phobia,
this project may identify Cue Labeling as a method for enhancing standard therapies for addiction. Part of the
appeal of the Labeling technique is its simplicity and low cognitive demand, important advantages in
substance use disorder and particularly during withdrawal, when cognitive function may be compromised.

Public health relevance
PROJECT NARRATIVE Nearly 70% of U.S. adults who smoke cigarettes want to stop smoking, but only 7.5% manage to maintain abstinence. Craving and negative emotions are major factors in lapses in abstinence. This application proposes to examine a novel and simple approach that can target both factors.